Development of analytical methods for detecting microcystins in fish tissue

The proposed project should enhance the safety of human and animal foods. The Analytical Toxicology
Section of the California Animal Health and Food Safety laboratory (CAHFS) is requesting funding to
develop analytical methods for detecting microcystins in fish tissues with the goal of assessing and
preventing contamination of fish based foods and feeds in the food supply of the domestic animal and
human food chain. Microcystins are an important One Health issue, in that it impacts wildlife, domestic
animals, and people alike. They are found in both degraded and oligotrophic waterways and can
contribute significant damage to ecosystems.

Public health relevance
Toxic freshwater harmful algal blooms (HABs) are caused by cyanobacteria that produce a variety of cyanotoxins, the microcystin group being the most common. Environmental degradation has increased the frequency of HABs. Microcystins bioaccumulate in aquatic animals, posing a risk to the human food chain. We will develop an liquid chromatography- mass spectrometry method (LC/MS) for detecting toxic microcystins in edible fish.